Cerebral Microvascular Bioenergetics and Neurovascular Coupling

Summary
Brain microvessels play an important role in the neurovascular coupling (NVC). Mitochondria are energy sensors
of cells. My work for the first time demonstrated the link between mitochondrial depolarization and activation of
nitric oxide synthases (NOS). Recently, we have made a novel discovery of a neuronal NOS (nNOS) isoform in
endothelial cells that uniquely produce reactive oxygen species (ROS). The nNOS is co-expressed with NO-
producing eNOS in endothelial cells and both isoforms are involved in the bidirectional regulation of
mitochondria. Diabetes mellitus (DM) increases the risk of cerebrovascular dysfunction and dementia.
Importantly, hypoglycemia is a dangerous side effect of DM treatments, particularly insulin-therapy. Patients with
DM often experience mild hypoglycemia, but these episodes are unaccounted for in determining the
cardiovascular morbidity and mortality. We achieved a technological breakthrough utilizing Seahorse XFe24
analyzer and determined the mitochondrial respiration and cellular bioenergetics of brain microvessels. We made
a novel observation that five episodes of recurrent hypoglycemia (RH) impaired the microvascular mitochondrial
function. Notably, single episode of acute mild or severe hypoglycemia as well as Impairments of NOS activity
was found to mediate RH-induced alterations of cellular bioenergetics. Thus, we hypothesize that mild RH
disrupts NVC by promoting microvascular mitochondrial dysfunction leading to impaired cognitive function. We
further hypothesize that increased nNOS-induced oxidative stress coupled with reduced eNOS-derived NO
contribute to the mitochondrial dysfunction following RH. We propose to use streptozotocin treated C57Bl/6 mice
and db/db mice with leptin receptor mutation as models of diabetes with untreated mice as controls. In addition,
we will employ eNOS knockout and inducible endothelial cell specific nNOS knockout mice to investigate the
role of NOS isoforms in RH-induced microvascular dysfunction. Each animal will be subjected to five episodes
(one per day) of mild (blood glucose 70-80 mg/dl) or severe (blood glucose 40-54 mg/dl) insulin-induced
hypoglycemia or saline control. Aim 1 is to demonstrate that mild and severe RH (in vivo) can increase the
production of NOS-derived ROS and display RH-induced functional mitochondrial respiration deficits in cerebral
microvessels (ex vivo). Aim 2 is to establish the impact of RH on NVC in vivo. We will determine the RH-induced
deficits in NVC by measuring the changes in arteriolar and capillary diameter in response to neuronal activation
(whisker stimulation) in awake mice using two-photon laser scanning microscopy. Aim 3 is to determine the
impact of RH on cognitive function using novel texture discrimination task and modified Y-maze test. The results
of this proposal would identify the mechanistic link between mild RH and the cerebral microvascular mitochondria
dysfunction and challenge the existing dogma to demonstrate that mild RH is equally detrimental as severe RH
in contributing to the DM-induced cerebrovascular dysfunction, impaired NV, and cognitive dysfunction.

Public health relevance
PROJECT NARRATIVE Brain microvascular dysfunction leads to impairments of neurovascular coupling leading to cognitive dysfunction. Mitochondria are cellular energy sensors and impairments of cellular bioenergetics alter the neurovascular coupling. We believe that selective targeting of endothelial variant of neuronal nitric oxide synthase isoform, as we propose, could benefit the brain by protecting microvasculature from hypoglycemia-induced mitochondrial damage.